C-KIT SIGNALING IN COLLATERALS REMODELING

TITLE: C-KIT SIGNALING IN COLLATERALS REMODELING
Critical limb ischemia (CLI) is the most advanced form of peripheral arterial disease. At the moment,
endovascular procedures and bypass surgeries are the only effective treatments for limb
revascularization. However, a significant proportion of CLI patients are not good candidates for these
interventions, requiring primary amputation as the main treatment option. Therefore, an effective
pharmacological strategy that prevents CLI and its devastating consequences represents a much-
needed alternative for this patient population. Arteriogenesis is a physiological compensatory process
in which pre-existing collaterals enlarge and serve as natural bypasses to severe occlusion of arteries.
We have recently identified that the c-Kit receptor tyrosine kinase plays a key role in the remodeling of
collaterals during arteriogenesis. We found that defective c-Kit function compromises blood flow
recovery after hindlimb ischemia, which was not resolved with hematopoietic reconstitution of c-Kit
activity. We have confirmed defective arteriogenesis in c-Kit mutant mice compared to controls.
Mechanistically, we advanced our understanding of how the c-Kit/Kruppel-like factor 4 (KLF4) pathway
orchestrates collateral remodeling. Therefore, our central hypothesis is that c-Kit/KLF-4 signaling
controls the recovery of the smooth muscle cell (SMC) contractile phenotype at the maturation phase of
arteriogenesis to prevent excessive remodeling and narrowing of collaterals. We propose two Specific
Aims (SA) to test our hypothesis. In SA1, we will demonstrate the involvement of vascular c-Kit
signaling in arteriogenesis. We will investigate whether inactivation or activation of c-Kit specifically in
SMCs will lead to dysfunction or optimal arteriogenesis in unique transgenic models of loss- and gain-
of-function of c-Kit, respectively. We will also identify molecular mechanisms that can be altered by the
loss- or gain-of-function on SMC c-Kit. In SA2, we will dissect the molecular pathways upstream and
downstream of c-Kit in SMCs. First, we will investigate whether cyclic strain dictates the oscillatory
expression of the c-Kit receptor by activating protein kinase C, leading to c-Kit suppression. Next, we
will determine whether c-Kit inhibits KLF4 through FBXO32-mediated ubiquitination, thereby restoring
the contractile SMC phenotype and preventing defective remodeling.
RELEVANCE: Approximately 80,000 major lower-extremity amputations occur in the United States
every year due to CLI. In this study, we will identify novel therapeutic targets to improve arteriogenesis
and prevent or alleviate the devastating effects of CLI. Moreover, we will identify the molecular
mechanism that dictates phenotypic switching in SMCs, which may be applicable to the understanding
and treatment of other vascular occlusive diseases.

Public health relevance
Despite treatments such as endovascular procedure and open bypass surgeries, thousands of Americans suffer from major vascular lower amputation due to end stages of critical limb ischemia (CLI). This study aims at identifying a novel pharmacological target in vascular c-Kit signaling that will enhance arteriogenesis in CLI. Therefore, outcomes from these studies may represent a breakthrough that will provide new therapeutic targets and strategies to protect against the devastating morbidity suffered by CLI patients.